C6-Development and adaptive myelination

PROJECT SUMMARY
During development, oligodendrocyte precursor cells (OPCs) widely dispersed into surrounding areas of gray
matter (neuronal cell bodies) or white matter (axon fiber tracts). As development proceeds into postnatal stages,
OPCs readily differentiate to give rise to oligodendrocytes, which are responsible for insulating neuronal axons
with myelin sheath. Interestingly, many OPCs remain undifferentiated into adult stages where they have been
shown to play an important role in adaptive myelination, a neuronal activity driven, experience-mediated process
that is essential for various forms of learning and memory. Previous studies show that OPCs are vulnerable to
the effects of developmental alcohol exposure, resulting in a decrease or delay in differentiation and myelination
of major white matter tracts in the brain. It is possible that these myelination deficits, especially in brain regions
critical for learning and memory, may directly contribute to the neurodevelopmental and behavioral abnormalities
observed in individuals with fetal alcohol spectrum disorders (FASDs). However, how developmental alcohol
exposure impacts the gene expression and function of OPCs and oligodendrocytes, and their roles in myelin
plasticity during learning and memory remains to be elucidated. To bridge this gap in knowledge, this component
aims to pursue the following specific aims in a third trimester equivalent mouse model of alcohol exposure (TTAE)
in which oligodendrogenesis and myelination are compromised in the brain.
Specific Aim 1. To determine the effects of developmental alcohol exposure on transcriptional programs
essential for differentiation of OPCs into oligodendrocytes in gray matter and white matter in the brain.
Specific Aim 2. To determine the impact of developmental alcohol exposure on activity-dependent, experience-
mediated myelin plasticity in early adulthood.
We anticipate that the completion of these aims will provide important clinical implications regarding strategies
to pharmacologically stimulate the myelination capacity of OPCs and oligodendrocytes to reverse the myelination
deficits seen in those affected by FASD.

Public health relevance
PROJECT NARRATIVE Prenatal alcohol exposure (PAE) is the most common environmental cause of neurodevelopmental brain injury resulting in the development of fetal alcohol spectrum disorders (FASDs). Children with FASD exhibit persistent learning and behavioral disabilities, which may be due to white matter injury in the brain. The goal of our study is to investigate how alcohol impacts the gene expression and function of oligodendrocytes, the major glial cell type that is responsible for myelinating white matter tracts in a mouse model of FASD.